Leadership and Administrative Core

Alzheimer’s disease (AD) is a major and increasing public health crisis in the United States (US) and a growing
health disparity, with African Americans (AAs) at disproportionate risk for AD and related dementias (ADRD)
compared to non-Hispanic Whites.1, 2 We seek to build on the experience of an interdisciplinary team in
AD/ADRD-relevant research to support diverse early career researchers and mid-career scientists newly
transitioning into AD/ADRD-relevant research carrying out research of high quality intended to prevent
cognitive and functional decline in minority older adults and reduce racial disparities of AD/ADRD. The faculty
of this AD-RCMAR are from the Johns Hopkins Schools of Public Health, Nursing, and Medicine, Morgan State
University, and Hampton University and have decades of experience working with African American, Hispanic,
and Asian American older adults, and the community organizations that serve them. All are nationally
recognized mentors with substantial experience training under-represented minority scholars. The overall aims
for this renewal application of the Leadership and Administrative Core (LAC) are to provide governance and
administration of the Center, to facilitate the training and development of RCMAR Scientists from
underrepresented backgrounds, and to advance the field of minority aging research on AD/ADRD. The LAC
will provide essential leadership and structure for this AD-RCMAR and its mentoring, data collection, analysis,
intervention, implementation, and dissemination activities, providing coordination and integration across the
Cores and Pilot Studies, while maintaining communications with the RCMAR Coordinating Center, other NIA
Research Centers, and external funding and oversight entities. The LAC will work closely with the Research
Education Component, Community-Liaison and Recruitment Core, and the Analysis Core to accomplish these
aims, thereby advancing our understanding of social and behavioral aspects of minority aging to ameliorate
disparities relevant to AD/ADRD. The MPI’s (Drs. Thorpe and Gallo) will be responsible for oversight of all
Center activities to ensure accountability and responsiveness to evolving scientific opportunities and public
health needs, including quality control of research, protection of human research participants, supervision of
administrative functions, fiscal oversight, interfacing with the External Advisory Committee, and liaison with
grant agencies and officials of Johns Hopkins University and participating Centers and Universities.